Better Info on Women's PrEP Choices and Outcomes in Malawi

Project Summary/Abstract
The goal of this study is to understand PrEP user choices, preferences, and implementation impact of the roll-
out of long-acting injectable (LAI) PrEP alongside oral PrEP among women in Malawi. As the roll-out of
expanded PrEP options increases globally, there is growing excitement that this could accelerate progress
towards ending HIV and provide discreet, user-controlled prevention options for women. Yet, real-world
choices and switches between oral and injectable PrEP products have not been evaluated on a large-scale
and high rates of product continuation are not guaranteed as has been demonstrated with oral PrEP use
globally. Thus, it is critical to understand PrEP user patterns and outcomes of PrEP implementation early
during the expansion phase of new biomedical technologies. The PathToScale is already funded – it is an
implementation science study which is rolling out injectable PrEP in Malawi to 9,900 people in real-world
conditions in January 2024, alongside further PEPFAR supported allocations for oral PrEP. The proposed
BetterInfo on PrEP study will leverage the PathToScale platform and critically extend work to evaluate use
patterns, preferences, and decision-making among women discontinuing PrEP whose choices and outcomes
will remain unknown in the absence of the proposed BetterInfo study. Specific Aim 1: Evaluate longitudinal
patterns of oral and long-acting injectable PrEP use in women in Malawi and the impact of BetterInfo tracing
approach on re-engagement in PrEP care. Specific Aim 2: Assess decision-making among injectable and oral
PrEP users and providers, as well as preferences for implementation delivery and support. In-depth interviews
with five sub-sets of PrEP user types traced (n=80) and healthcare providers/implementing partner
stakeholders (n=16) will explore decision-making and implementation and behavioral facilitators and barriers to
oral and injectable PrEP use guided by the theoretical domains framework (TDF) and COM-B model. Further,
a discrete choice experiment/best worst scaling will be conducted among the sub-sample of traced
discontinued PrEP users who remain at high risk for HIV acquisition (n=~270) to better understand preferences
around PrEP product choice, clinical support and re-engagement strategies. Specific Aim 3: Co-design
strategies for optimizing PrEP continuation and re-engagement to achieve implementation impact for
women in Malawi by combining scenario-modeling and human centered design (HCD) workshops. This
will be achieved by leveraging PathToScale and BetterInfo tracing data within mathematical models to estimate
the comparative, community-level transmission impact of oral and injectable PrEP implementation strategies
under different trajectories of PrEP use, and co-designing PrEP engagement and provider communication
strategies through HCD workshops with the community partnership council, MOH and implementing
partners/providers and clients, factoring in data across aims.

Public health relevance
Project Narrative This implementation science grant aims to understand PrEP user choices, preferences and implementation impact of the roll-out of long-acting injectable (LAI) PrEP alongside oral PrEP among women in Malawi. The design will: (1) evaluate longitudinal patterns of oral and long-acting injectable PrEP use in women in Malawi and the impact of tracing on re-engagement in PrEP care; (2) assess decision-making among injectable and oral PrEP users and providers, as well as preferences for implementation delivery and support; and (3) synthesize evidence and local inputs to design strategies for optimizing PrEP continuation and re-engagement to achieve implementation impact for women in Malawi. Findings will provide clarity around PrEP users patterns and outcomes of PrEP implementation and support the development of PrEP engagement interventions co-designed with the Community Partnership Council (CPC), Ministry of Health, implementing partners, providers, and PrEP users.